MECHANISMS OF MOLECULAR TRACKS AND MOTORS

Myosins are the molecular motors that power muscle. They are also responsible for many events inside cells where they are involved in cell division (cytokinesis), targeting cargos to different regions of the cell (vesicle trafficking) and the development and maintenance of cellular architecture. Defects in myosins can lead to life threatening disease. Over the lastdecade, a synthesis of structural, biochemical and biophysical data has resulted in a general model for how these molecular motors work. Many of the experiments proposed in this application are designed to test fundamental aspects of the model that have been called into question by some recent publications. Cryo-electron microscopy and image analysis will be used to examine recombinant determine which regions of the molecule determine directionality, processivity and experiments will reveal the organization, structure and regulatory role of the myosin domain, the structure and actions of myosin IX, and the ADP response of a myosin provide native and recombinant proteins. Planned technical developments include image processing approach to increase the resolution attainable in the 3D maps. myosin VI motors to step size. Additional VI light chain binding I. Collaborators will using a single particle